Dissemination of MAPseq and BARseq for High-Throughput Brain Mapping

The goal of this project is to disseminate MAPseq and BARseq to the broader neuroscience
community. These are novel methods developed in my laboratory based on high-throughput DNA
sequencing for determining neuronal circuitry. Neurons transmit information to distant brain
regions via long-range axonal projections. In some cases, functionally distinct populations of
neurons are intermingled within a small region. Disruptions of connectivity may underlie many
neuropsychiatric disorders including autism and schizophrenia.
At present, neuroanatomical techniques—particularly those with single neuron resolution—are
expensive and labor intensive. MAPseq and BARseq convert neuroanatomy into a problem of
DNA sequencing, and thereby allow us to exploit the tremendous breakthroughs in next-
generation sequencing throughput. The dissemination of these high-throughput methods for
determining neuronal projections will have important implications for understanding normal
neuronal circuitry, and how this circuitry is disrupted in animal models of neuropsychiatric
disorders like autism and schizophrenia.

Public health relevance
The central goal of this proposal is to disseminate MAPseq and BARseq to the broader neuroscience community. The dissemination of these high-throughput methods for determining neuronal projections will enable many laboratories to use these methods to understand normal neuronal circuitry, and how this circuitry is disrupted in animal models of neuropsychiatric disorders like autism and schizophrenia.